Health, Air Pollution, and Population Initiative in Education and Science Training (HAPPIEST)

PROJECT SUMMARY
The overall goal of this project is to train University of Utah (UOU) undergraduate students from
underrepresented racial/ethnic backgrounds in air pollution-related health research through a faculty-mentored
summer program called Health, Air Pollution and Population Initiative in Education and Science Training
(HAPPIEST). Since exposure to air pollution is magnified in racial/ethnic minority communities in the US, it is
imperative to engage members of these communities—especially college students interested in STEM
research—in addressing the complex problems caused by poor air quality and environmental inequity. Specific
aims are to:
1. Implement a comprehensive strategy to recruit UOU students from underrepresented backgrounds
into the HAPPIEST R25 program.
2. Immerse undergraduate students in a mentoring “community of practice” founded on an
interdisciplinary, team-based approach to environmental health research, specifically as it relates to
air pollution.
3. Utilize formative and summative evaluation to improve the quality and effectiveness of HAPPIEST as
well as inform future undergraduate research training programs that aim to increase the participation of
underrepresented groups in NIEHS-related research.
The “community of practice” is comprised of four research teams, each with two undergraduate students, one
graduate student training coordinator, and at least one faculty mentor. Teams will work on locally-relevant air
pollution and health research, with the potential for interdisciplinary integration across teams. HAPPIEST will
serve a total of forty undergraduates over the five years of the project. The program directors will implement
strategic activities for student recruitment, research training, professional development, and mentoring. Using
an asset-oriented approach designed to build on student strengths, HAPPIEST activities will prepare students
for placement into competitive graduate programs in the environmental health sciences. The project is of great

Public health relevance
PROJECT NARRATIVE The proposed project seeks to train University of Utah undergraduate students from underrepresented racial/ethnic backgrounds in air pollution-related health research through the transdisciplinary faculty-mentored summer program Health, Air Pollution and Population Initiative in Education and Science Training (HAPPIEST). Exposure to air pollution is magnified in racial/ethnic minority communities, and it is thus critical to engage affected populations in this area of research. The proposed project's main contributions to public health are twofold: (1) HAPPIEST prepares underrepresented minority students to enter STEM research, thereby diversifying the pool of talented scientists; (2) the program advances knowledge in environmental health science thereby informing innovative solutions for air pollution-related health problems in the Salt Lake Valley and beyond.